MOLECULAR MECHANISM OF CRH EXPRESSION

This project examines the expression of the neuropeptide Corticotropin-Releasing Hormone (CRH) at the mRNA and peptide levels in the developing rat brain, utilizing techniques from the realms of molecular biology, quantitative neuroanatomy and behavioral neurophysiology. CRH was first found in the hypothalamus, where its effect on ACTH and glucocorticosteroid secretion in response to stressors is now well established. The role of CRH located in specific extra- hypothalamic brain regions is less well defined. Moreover, little is known about the CRH neuronal system in perinatal and immature animals. While during late fetal life steroid levels rise with noxious stimuli, there is a hiatus in their ability to generate a stress response in the first 2 weeks of life. A transient decrease in hypothalamic CRH content during the first postnatal days has been reported. We will study CRH-mRNA expression in selected brain regions of the developing rat, using in situ hybridization; peptide content of the same discrete brain regions will be assessed by radioimmunoassay of tissue specimen microdissected ('punched') from brain slices. We will manipulate peptide and/or mRNA content by altering hormonal feedback, to gain further insight into the molecular level of control mechanisms. The significance of the perinatal perturbations of the CRH neuronal system to seizure susceptibility will be explored. CRH has been shown to be a convulsant, causing epileptiform discharges and neuronal excitation in the amygdala, hippocampus and locus ceruleus in rats. Furthermore, a seizure disorder unique to infants responds to manipulations of the CRH system, while anticonvulsants are less effective. We will use the maximal electroshock seizure model and chemically induced seizures to study whether the CRH neuronal system and its manipulation, or exogenous CRH administration alter the suspectibility of the immature brain to seizures.